Role of the oral microbiome in driving local and systemic inflammation in HIV

PROJECT SUMMARY / ABSTRACT
Chronic HIV infection remains a public health challenge with nearly 38 million people worldwide living with
HIV/AIDS. Despite the success of antiretroviral therapy in suppressing ongoing viral replication, numerous
challenges remain including chronic inflammation and accelerated onset of comorbidities. Better understanding
of the mechanisms contributing to these phenomena is imperative to further reduce comorbidities and improve
treatment of HIV. The microbiome is comprised of trillions of diverse microbes (bacterial, fungal, viral), and
multiple lines of evidence highlight the connections between the microbiome, mucosal immune system, and
HIV-related inflammation. While the intestinal microbiome has been the focus of intense research, less is
known about the role of the oral microbiome in health and disease. In non-HIV settings, the oral microbiome
has been associated with increased risk of inflammation-related comorbidities such as cardiovascular disease.
Recent evidence has also highlighted the connection between the oral and gut microbiomes, and increased
colonization of aerotolerant “oral” bacteria in the gut has been observed in many inflammatory diseases,
including HIV. Studies examining the oral microbiome in the setting of HIV are limited, and none have
examined the relationships between oral to gut bacteria translocation, onset of dysbiosis, and systemic
inflammation in HIV. We hypothesize that bacterial translocation from the mouth to the gut contributes to the
development of dysbiosis in chronic HIV infection. Further, we hypothesize that the oral microbiome
contributes to local and systemic inflammation in chronic HIV, and this altered mucosal environment may
increase susceptibility for oral infections. Using longitudinal specimens, novel saliva analyses, and
epidemiologic clinical outcomes we will systematically address our hypotheses. We propose to: 1) determine
the contribution of oral microbiota to gut dysbiosis and systemic inflammation in persons living with HIV; 2)
define the relationship between salivary IgA responses to key oral bacteria and local and systemic
inflammation; and 3) identify specific oral bacteria that may predict risk of oral sexually transmitted infections
(STI) in at-risk persons with and without HIV. This work will help better define the complex relationships
between the oral microbiome, inflammation, and infection susceptibility in HIV; a critical step for developing
novel strategies and saliva-based monitoring tools to better treat HIV and reduce comorbidities.

Public health relevance
PROJECT NARRATIVE This project explores the important question of how oral and gut microbes interact during HIV infection, and how these interactions may alter the immune environment in the mouth leading to inflammation and susceptibility to oral sexually transmitted infections (STIs). We will use longitudinal oral and gut microbiome profiling plus saliva antibody measures to investigate mechanisms leading to inflammation in HIV, and apply machine learning to identify microbiome signatures of STI risk. Results from this study could aid in developing novel strategies and saliva-based monitoring tools to better treat HIV and reduce comorbidities.